Intersection of Neuro-Immune-Vascular Dynamics in Preclinical NeuroHIV Model

SUMMARY
Following systemic infection, HIV-1 enters the CNS by a “Trojan horse” mechanism, using infected monocytes
or T-cells from the periphery to cross the blood-brain barrier (BBB) and infect CNS cells. Within the CNS,
microglia (MG), resident macrophages (MΦ), serve as reservoirs for HIV-1. Although neurons are not directly
infected, they appear highly susceptible to dysfunction due to the presence of the virus in the CNS. HIV-1
infection leads to BBB dysfunction, exacerbating viral replication within the CNS. Inflammatory factors
released by infected MG/MΦ contribute to selective synaptic damage in neurons, gradually resulting in CNS
pathology. This neuronal dysfunction manifests as impaired cognitive function, known as HAND, affecting 30-
50% of HIV-1 individuals regardless of antiretroviral treatment. The goal of this proposal is to develop new
insights into how HIV-1 affects the brain, recapitulate aspects of BBB and CNS pathology in a highly
controllable manner and define the pathogenic state of CNS HIV-1 infection. We will develop a next
generation preclinical model of NeuroHIV, that better recapitulate neuro-immune-vascular system interactions
in the context of ART-mediated HIV suppression. We will incorporate peripheral immune cells that support a
natural route of HIV entry across the BBB into the CNS, glial cells relevant to the neuropathogenesis of HIV
infection, neurons, brain endothelial cells and BBB supporting cell types. We propose the following aims to
achieve the goals. Aim 1 (R61), Generate, characterize and validate iPSC-derived CNS cells and immune
cells. Aim 2 (R61), Establish a perfused HIV-1 blood-BBB/CNS model. Milestones of the R61 phase will be
to validate iPSC types, optimize protocols and demonstrate reliable HIV-1 infection of MG/MΦ, establishment
of at a HIV-CNS 3D model with flow, test MΦ’s BBB transmigration and finally to optimize protocols to track
the spread of HIV-1GFP infection within the CNS compartment. Finally Aim 3 (R33), we will create a 3D blood-
BBB/CNS model with flow, which dynamically examines neuro-immune-vascular “circuit responses” in the
context of ART-suppressed HIV-1 infection. By creating the first 3D human HIV-1 blood-BBB/CNS model that
allows for single-cell imaging and transcriptomic analysis, we have a unique opportunity to recapitulate the
clinical picture of NeuroHIV, including neurological endpoint measures. This model will enable us to study
how HIV expression drive pathogenic neuro-immune-vascular “circuit responses” in the context of an ART-
suppressed infection and to examine the potential neurotoxic effects of ART therapies themselves. The
proposal addresses significant knowledge gaps related to the disease etiology of NeuroHIV in clinical
populations on ART, with a high potential for overall impact.

Public health relevance
PROJECT NARRATIVE This project aims to develop new insights into how HIV-1 affects the brain, recapitulate aspects of BBB and CNS pathology in a highly controllable manner and define the pathogenic state of CNS HIV-1 infection. We will develop novel preclinical NeuroHIV models of the cART era, to investigate dynamic vascular-neuro- immune circuit response changes of the BBB and CNS following cART-suppressed HIV-1 infection, as well as potential CNS toxicity of cART.